An allergen-specific immune signature-directed diet vs sham diet for treatment of eosinophilic esophagitis: A pilot-feasibility study

An allergen-specific immune signature-directed diet vs sham diet for treatment of eosinophilic
esophagitis: A pilot-feasibility study
ABSTRACT
Eosinophilic esophagitis (EoE) is a chronic disease defined by abnormal infiltration of eosinophils into the
esophageal mucosa, leading to dysphagia, progressive esophageal stenosis, and food impaction. The
incidence and prevalence are rising dramatically, and EoE is now a major cause of upper gastrointestinal
morbidity. Because EoE is allergen-mediated and triggered by foods, dietary elimination is the primary non-
pharmacologic treatment. However, the approach to dietary elimination is sub-optimal, burdensome, and time-
consuming. Currently available blood- or skin-based allergy tests do not reliably identify food triggers of EoE,
so multiple foods must be empirically removed from the diet. Adherence to these restrictive diets is difficult,
the same approach is used for all patients, and foods that are not eliminated may still be triggers. Multiple
endoscopies are required to identify triggers, and these invasive and costly procedures carry risks. Two major
issues must be addressed to allow widespread application of dietary therapy in EoE. First, if accurate allergy
tests were available, treatment could be personalized and streamlined. Foods likely to be triggers in an
individual patient could be eliminated, and foods unlikely to provoke eosinophilic inflammation could be
retained. Second, if non-invasive biomarkers were available to monitor treatment response, the need for
endoscopies could be greatly reduced. To begin to address these two major knowledge gaps, we developed a
novel allergen-specific immune signature to guide dietary elimination. This technique predicts food triggers
based on food-specific IgG4 levels in esophageal biopsies and CD4+ T-cell stimulation assays in peripheral
blood. In initial testing, this approach was more accurate than traditional skin-based allergy tests. We have
also identified a promising biomarker, eosinophil peroxidase (EPX), that can be measured in the serum and
tracks with treatment response as measured on esophageal biopsies. The proposed study has been designed
to be highly responsive to PAS 20-160, a new “small R01” mechanism that encourages pilot/feasibility clinical
trials that lay the foundation for larger trials. To generate key data to estimate effect sizes, we will conduct a
pilot randomized clinical trial of the allergen-specific immune signature-directed diet elimination vs sham diet
elimination with the following specific aims: 1) To estimate the effect of allergen-specific immune signature-
directed dietary elimination compared to sham elimination on esophageal eosinophil counts and symptoms of
dysphagia in patients with EoE; and 2) To assess serum EPX as a non-invasive biomarker and estimate effect
sizes for monitoring dietary elimination treatment response in patients with EoE. This innovative pilot/feasibly
trial will be conducted by an existing multidisciplinary team with recognized expertise in EoE, clinical trials, food
allergy, pathology, and translational science. It will ultimately lead to a major clinical impact on the treatment
and monitoring of EoE by individualizing dietary elimination and streamlining monitoring of dietary elimination
using non-invasive biomarkers, so patients can avoid the time, effort, and risk of empiric dietary elimination.

Public health relevance
NARRATIVE Eosinophilic esophagitis (EoE), a recently recognized disease with rapidly increasing incidence, prevalence, and recognition, is characterized by the abnormal presence of eosinophils in the esophageal lining, leading to difficulty swallowing, progressive esophageal stenosis, and food impaction. The goals of this pilot/feasibility project are to estimate the effect of allergen-specific immune signature-directed dietary elimination compared to sham elimination on esophageal eosinophil counts and symptoms of dysphagia in patients with EoE, and assess serum eosinophil peroxidase as a non-invasive biomarker to estimate effect sizes for monitoring dietary elimination treatment response in patients with EoE. The proposed research will set the stage for a definitive clinical that will impact the treatment and monitoring of EoE by individualizing dietary elimination and streamlining monitoring of dietary elimination using non-invasive biomarkers, so patients can avoid the time, effort, and risk of repeated endoscopies to identify dietary triggers.